MKL in megakaryocytopoiesis

DESCRIPTION (provided by applicant): Megakaryocytopoiesis is the process by which egakaryocytes differentiate from biphenotypic megakaryocyte-erythroid precursors, to megakaryoblasts, which undergo endomitosis to become polyploid, and subsequently undergo maturation to mature megakaryocytes that can release platelets into the circulation. Each of these stages is critical for the cells to produce function platelets, which are critical for hemostasis. Despite great advances in our understanding of hematopoiesis, relatively little is known regarding how megakaryocytopoiesis is regulated, and how this may go awry in diseases of megakaryocytes affecting platelet formation and in acute megakaryoblastic leukemia (AMKL). This proposal is focused on determining the mechanism(s) by which MKL1 promotes megakaryocytic differentiation. MKL1 was first identified by its involvement in the t(1;22) translocation, which occurs almost exclusively in AMKL of newborns. To understand the mechanism by which the RBM15-MKL1 fusion protein encoded by the t(1;22) translocation promotes leukemia, we must understand the normal functions of RBM15 and MKL1 in hematopoiesis, which have only recently begun to be elucidated. My laboratory has discovered several important clues regarding the normal function(s) of MKL1: 1) MKL1 is differentially expressing during megakaryocytic differentiation with the highest levels in the most mature polyploid megakaryocytes (Mks), 2) overexpression of wildtype (WT) MKL1 promotes Mk differentiation of human cell lines as well as primary murine and human cells with increased numbers of Mk and increased ploidy of Mk, 3) MKL1 knockout mice have impaired megakaryocytic differentiation and decreased platelet numbers, 4) notch stimulation promotes Mk differentiation and 5) MKL and notch act synergistically on both SRF and notch responsive promoters. The aims of this proposal build upon these observations to elucidate the mechanisms by which MKL1 promotes megakaryocytopoiesis. Aim 1 is to determine the functional interactions of MKL1 with SRF and MKL2 in megakaryocytopoiesis using in vivo and in vitro approaches. Aim 2 is to test hypothesis that MKL1 and notch act synergistically to promote megakaryocytic differentiation. Aim 3 is to assess the mechanism by which MKL1 promotes polyploidization of megakaryocytes. The clinical relevance of the proposed work is clear - these studies will help to elucidate the mechanisms underlying normal megakaryocytopoiesis, which is key for normal formation of functional platelets. In addition, these studies will form the basis for future studies on the RBM15-MKL fusion protein found uniquely in AMKL, which accounts for 10% of AML cases in children. PUBLIC HEALTH RELEVANCE: The platelets in our blood are critical for prevention f bleeding. Platelets are formed in the bone marrow from cells called megakaryocytes. The work proposed is focused on a obtaining a better understanding of the process of megakaryocytopoiesis with the long-term goals of deriving effective therapies for genetic and acquired diseases affecting these cells. Acute megakaryoblastic leukemia (AMKL) affects primarily newborn infants and children during the first year of life. When AMKL is associated with a t(1;22) chromosomal translation between the RBM15 gene on chromosome 1 and the MKL1 gene on chromosome 22, there are few effective treatment options, and the disease is nearly always fatal. In this new application, we propose to build on our published work and preliminary data elucidating the role of MKL1 in normal and malignant megakaryocyte expansion, polyploidization and maturation. Specifically, we are assessing the role of MKL1 in megakaryocyte differentiation, and the mechanisms underlying its action. The results of these studies will provide new insights into the role of MKL1 in normal as well as malignant cells.)

Public health relevance
Project Narrative The platelets in our blood are critical for prevention of bleeding. Platelets are formed in the bone marrow from cells called megakaryocytes. The work proposed is focused on a obtaining a better understanding of the process of megakaryocytopoiesis. With the longterm goals of deriving effective therapies for genetic and acquired diseases affecting these cells. Acute megakaryoblastic leukemia (AMKL) affects primarily newborn infants and children during the first year of life. When AMKL is associated with a t(1;22) chromosomal translation between the RBM15 gene on chromosome 1 and the MKL1 gene on chromosome 22, there are few effective treatment options, and the disease is nearly always fatal. In this new application, we propose to build on our published work and preliminary data elucidating the role of MKL1 in normal and malignant megakaryocyte expansion, polyploidization and maturation. Specifically, we are assessing the role of MKL1 in megakaryocyte differentiation, and the mechanisms underlying its action. The results of these studies will provide new insights into the role of MKL1 in normal as well as malignant cells.)